EFFECT OF HEPARINE ON ENDOTHELIN LEVELS IN PATIENTS WITH CHF

The hypothyses of intravenous administration of a continuous infusion of heparin will result in the suppression of endothelium-l concentrations in patients with heart failure and discontinuation of heparin results in a 'rebound'increase in ET-1 concentrations will be tested.